The Mutant Mouse Resource and Research Center at the University of Missouri

PROJECT SUMMARY - OVERALL
The Mutant Mouse Resource and Research Center (MMRRC) is the nation’s primary mutant mouse archive
and distribution repository system, the primary goal of which is to facilitate research by identifying, acquiring,
evaluating, characterizing, cryopreserving, and distributing mutant mouse strains to qualified biomedical
investigators. The MMRRC was established by the NIH to ensure the preservation, dissemination, and
development of valuable mutant mouse lines and data generated by research scientists. The MMRRC is a
consortium of four Centers, each hosting an archive and distribution repository, and an Informatics
Coordination and Service Center (ICSC) within a trans-national network regionally distributed across the
United States. The Centers collectively serve the needs of the nation’s biomedical research community,
ensuring access to and optimizing utilization of transgenic, knockout, and other genetically engineered mutant
mice and related biomaterials, services, and new technologies. The Centers import, verify, maintain, and
distribute mice, gene-targeted embryonic stem (ES) cells, and germplasm of genetically unique, scientifically
valuable mice. Centers also provide services and procedures to assist investigators using genetically altered
mice for research. Finally, Centers conduct resource-related research, often collaboratively, to further refine
and develop mutant mouse lines and capitalize on the power of mouse genetics for biomedical research. By
depositing their mutant mice in repositories at the Centers, NIH-funded investigators fulfill their obligation under
the NIH Sharing Policy. In return, each of the Centers strives to preserve, protect, quality control, and provide
these models for the benefit of research scientists and investigators across the nation and the globe. In doing
so, the MMRRC ensures that valuable mutant mouse lines are available equitably across the biomedical
research community, thereby accelerating the pace of research and discovery using genetically altered mice.

Public health relevance
PROJECT NARRATIVE Genetically-engineered mice are instrumental to better understand human development and disease and to develop and improve drugs and therapeutics. The Mutant Mouse Resource and Research Center at the University of Missouri provides a unique repository for importing, storing and distributing a vast number of genetically-engineered mice, germplasm, embryonic stem cells and related reagents. The center also performs critical broad-based research and services to ensure quality, reproducibility and translatability of mouse models with an emphasis on the role of complex gut microbiota in model phenotypes.